Targeting Lysosome Function in Lipid Overload Cardiomyopathy

Project Abstract
The goals of this project are two-fold: 1) to evaluate the role of lysosomal dysfunction in lipotoxic cardiomyopathy
and 2) to provide mentorship and training to allow the PI’s transition to independence. The prevalence of diabetes
and obesity are increasing in the population, and both conditions are independent risk factors for the
development of heart failure. Cardiac lipotoxicity has been identified as a potential pathway through which
diabetes causes cardiomyopathy, but the understanding of how lipid overload disrupts cardiac function remains
limited. Preliminary data acquired by the PI demonstrate that lipid overload-induced cardiac dysfunction is
rescued by intermittent fasting. Intermittent fasting does not reduce cardiac triglyceride levels, but protein
aggregate pathology is attenuated. Also, the levels of specific cardiac ceramide species are altered, suggesting
that the effect of intermittent fasting is medicated by changing the level of individual lipid species, rather than
overall reduction in lipids. Based on this data, this project hypothesizes that myocardial lipid overload impairs
lysosome function via ceramide accumulation to induce cardiomyopathy and that stimulation of lysosomal
biogenesis program by TFEB activation is sufficient to rescue this outcome. This hypothesis will be tested by
assessing autophagic flux and lysosomal function in mice models of cardiac lipid overload and in cultured
cardiomyocytes under lipid stress (Aim 1), examining cardiac lysosomal ceramide accumulation under lipid
stress and the requirement for ceramide synthesis in cardiac lipotoxicity (Aim 2), and evaluating the role of TFEB
in stimulating lysosomal biogenesis to improve lipotoxic cardiomyopathy (Aim 3). Completion of these aims will
address knowledge gaps in the field of cardiac lipotoxicity and also provide training to facilitate the career
development of the PI. The PI has previously obtained PhD training in molecular and cellular biology and has
undertaken postdoctoral training in the lab of Dr. Abhinav Diwan, following completion of clinical training in
medicine and cardiology. The PI seeks additional scientific training in a mentored setting to address the
knowledge gaps described. Specifically, the proposed career development plan will provide additional training
in 4 areas: 1) autophagy and lysosomal biology, 2) lipid biology and lipidomics, with a focus on sphingolipid
biology, 3) echocardiographic analysis of animal models of cardiac disease, and 4) training in grant writing,
presentation skills, and leadership. This plan will be guided by mentorship and research support from Dr. Abhinav
Diwan and Dr. Douglas Mann, experts in lysosomal biology and myocardial biology, respectively, as well as by
additional mentorship from the advisory committee with renowned expertise in lysosomal biology (Dr. Stuart
Kornfeld), lipid biology (Dr. Brian Finck and Dr. Clay Semenkovich), and sphingolipid biology and lipidomics (Dr.
Ashley Cowart). This training and mentorship in a highly supportive institutional training environment will enable
the PI to develop into an independent cardiovascular investigator and physician-scientist focused on studying
the role of lysosomes in cardiovascular development and in the myocardial response to injury.

Public health relevance
Projective Narrative Diabetes and obesity increase the toxic lipid accumulation in the heart and increase the risk of developing heart failure. The mechanisms through which lipids cause heart injury is unclear, and thus there are no available therapies targeting this process. I propose to study the role of lysosomal biogenesis and function in cardiac lipid overload, with the goal of developing therapies to improve this condition and prevent heart failure.